Personalized Mapping of Affective Lability

PROJECT SUMMARY
Affective lability (AL) is a common psychiatric symptom characterized by rapid mood fluctuations. Clinically
significant AL often begins in adolescence, is present in both psychiatric disorders and the general population,
and is a major risk factor for suicide. However, the developmental substrates of AL remain only sparsely
described. Prior studies have implicated deficits of top-down regulation between the frontoparietal network
(FPN) and the amygdala; the FPN is also known to undergo protracted maturation into young adulthood.
However, previous efforts have been limited by methodological obstacles related to underlying biological
heterogeneity of the FPN. Cortical networks have typically been studied using standardized network atlases,
which assume a 1:1 mapping between structural and functional neuroanatomy across individuals. However,
recent studies using precision functional mapping techniques have demonstrated reliable individual differences
in functional topography, i.e., the spatial distribution of functional networks on the cortex. Notably, the FPN is
both critical for affect regulation and also has the most variable functional topography of any cortical network.
This proposal will capitalize upon new machine learning tools to map the FPN on a personalized basis to test
the over-arching hypothesis that AL is associated with developmental abnormalities of FPN topography and
connectivity. In Aim 1, we will continue to acquire a sample of 30 adolescents and young adults (ages 16-21)
with affective lability and 20 matched comparators using smartphone-based digital phenotyping and multi-
modal imaging. In Aim 2, we will capitalize upon a recently-completed longitudinal study (n=200, 10-25 years
old, mean follow up interval = 5 years) that will allow us to understand how longitudinal changes in
personalized FPN topography and connectivity associate with AL. Taken together, this project will provide
valuable new insights regarding circuit-level developmental deficits associated with AL, and provide the
candidate with superb training in computational psychiatry.

Public health relevance
PROJECT NARRATIVE Affective lability is a common symptom of multiple psychiatric conditions in youth and is one of the strongest predictors of suicide. Here, we propose to use machine learning tools to identify circuit-level deficits associated with affective lability in individual adolescents and young adults. This knowledge may be critical for the development of personalized therapeutics for the treatment of affective lability.